Mechanisms of impaired subcortical auditory processing in schizophrenia

Project Summary
Schizophrenia is among the most severe and burdensome medical conditions worldwide, yet the
pathophysiological basis for symptoms experienced by patients remain unknown. This F30 application
presents a research and training program that will support the applicant on a path towards becoming an NIH-
funded independent investigator and physician-scientist focused on understanding the neurobiology of
schizophrenia and related psychotic disorders. The activities in this application build on the candidate’s prior
training and are set in a resource-rich environment that will facilitate the development of expertise in: 1)
principles of clinical imaging in schizophrenia, 2) methods in cognitive neuroscience and functional magnetic
resonance imaging (fMRI), 3) model-based analysis of auditory processing using fMRI, 4), fundamentals of
clinical medicine and translational research, and 5) the responsible and ethical conduct of research.
This research proposal aims to determine the relationships between auditory verbal hallucinations (AVH)
experienced by individuals with schizophrenia and previous findings of: 1) impaired thalamocortical
connectivity in mouse models of 22q11 deletion syndrome (22q11DS), the strongest known genetic risk factor
for psychosis; 2) reduced resting-state functional connectivity between MGN and AC in patients with
schizophrenia; and 3) impaired computational processes in auditory cortex and MGN. The overarching goal of
the research to be carried out in this application is to use resting-state, task-based, and model-based multiband
fMRI to identify impairments that correlate with the presence and severity of AVH in: 1) connectivity between
medical geniculate nucleus (MGN) and auditory cortex (AC), and 2) auditory learning and percept generation
in medial geniculate nucleus.
I aim to study the following groups of individuals: unmedicated patients with SCZ and schizoaffective
disorder (n=30) and matched healthy controls (varying degrees of subclinical perceptual disturbances; n=30).
Using a thalamic localizer fMRI task, voxels comprising the medial geniculate nucleus will be identified in each
subject. Subsequently, resting-state functional connectivity (RSFC) between MGN and AC will be determined
using task-free fMRI. Using a model-based auditory discrimination fMRI task, neurocomputational
underpinnings of auditory learning and percept generation will be measured. Neurobiological impairments
detected via fMRI will be correlated with clinical measures of AVH severity. Such evidence would have
important implications for our understanding of the brain bases of auditory verbal hallucinations and the
pathogenesis of schizophrenia and would help generate new targets for treatment of this devastating illness.

Public health relevance
Project Narrative Schizophrenia is a widespread, poorly-understood disorder that poses a great social and economic burden in the United States and throughout the world. Auditory verbal hallucinations are a particularly devastating symptom of this disease in a significant percentage of patients, producing markedly increased risk for unemployment, homelessness, incarceration, chronic disability, and reduced life expectancy. By seeking to understand how abnormalities in brain function produce auditory verbal hallucinations, this project may help lead to the ability to identify individuals at risk for the disorder and improved treatment options for patients.